Coordinated suppression of hepatic steatosis via targeting of FLCN

PROJECT SUMMARY:
Nonalcoholic fatty liver disease (NAFLD) is a major public health issue affecting ~30% of Americans. If
left untreated, NAFLD can progress to nonalcoholic steatohepatitis (NASH), and then to cirrhosis and
hepatocellular carcinoma. The pathogenesis of NAFLD remains poorly understood. Identifying novel pathways
that can be targeted to improve NAFLD, and consequently NASH, is thus an imperative need. Given that
NAFLD is a disorder of abnormal liver lipid accumulation, it is logical that the pathogenesis involves nutrient
sensing pathways that regulate hepatic lipid homeostasis. To better probe these pathways in NAFLD, I set out
to study the protein folliculin (FLCN), which has recently been linked to nutrient sensing in adipose and other
metabolic tissues. Mechanistically, FLCN activates RagC, which then recruits mTORC1 to promote
cytoplasmic sequestration of the transcription factor E3 (TFE3), a key driver of lysosomal biogenic genes.
FLCN is expressed abundantly in the liver, but nothing is known of its role in this highly metabolic tissue.
My data show that liver-specific Flcn deletion powerfully protects against NAFLD in a TFE3-dependent
manner. Further preliminary data reveal Flcn liver deletion causes suppressed de novo lipogenesis (DNL)
genes, induced fatty acid oxidation (FAO) genes, increased liver triglyceride secretion, and increased hepatic
lipophagy. Thus, I hypothesize (aim 1) that, physiologically, Flcn deletion coordinates through these 4
pathways a coordinated program to prevent steatosis, and that these effects are TFE3-dependent; I will study
these pathways through state-of-the-art functional assays. I also hypothesize, (aim 2) mechanistically, that
Flcn-null livers are protected from NAFLD due to the inhibition of FLCN-driven RagC activation. This then
allows TFE3 to translocate into the nucleus and regulate a gene expression program to protect from steatosis,
specifically (1) competing with SREBP-1c to suppress DNL genes, and (2) inducing PGC-1alpha to activate
FAO genes, as suggested by my TFE3 ChIP-seq data. I will study these mechanisms through ChIP, luciferase
assays, and genetic mouse models. Finally, I hypothesize that (aim 3) Flcn liver deletion will also protect
against NASH, which I will test using a NASH-inducing diet and genetic mouse models. My work will illuminate
the role of FLCN in NAFLD and NASH, and if successful, will provide a promising target for future therapies.
These studies serve as the basis for my pre-doctoral fellowship application to the National Institute of
Diabetes and Digestive and Kidney Diseases awarded to M.D./Ph.D. applicants. My training plan is geared
toward becoming a physician-scientist: through the pursuit of this highly clinically relevant research topic and
through continued exposure to clinical medicine and translational research, I will develop the skills necessary
to blend clinical practice and basic science in my career. Moreover, training under the excellent mentorship of
a physician-scientist (Dr. Zoltan Arany) and being a part of the well-established M.D./Ph.D. program at the
University of Pennsylvania, I am in an ideal environment to pursue my dream career.

Public health relevance
PROJECT NARRATIVE: Nonalcoholic fatty liver disease (NAFLD) affects ~30% of individuals in the U.S., and if left untreated, it can progress to nonalcoholic steatohepatitis (NASH) and consequently to cirrhosis and hepatocellular carcinoma. The pathogenesis of NAFLD remains poorly understood, and thus identifying novel pathways that can be targeted to improve this spectrum of diseases is an imperative clinical need. My studies will shed light on the role of a novel protein folliculin in NAFLD and NASH, and given preliminary data that folliculin deletion may protect against these diseases, my work may provide a novel and promising target for future therapies against these major public health issues.